Training Program in the Genetic Basis of Pediatric Gastrointestinal Disorders

PROJECT SUMMARY/ABSTRACT
Training in the genetic basis of pediatric gastrointestinal disorders: The revolutions in genetics and
genomics have led to discoveries in a range of GI diseases, many of which affect the health of children.
Pediatric gastroenterologists who are trained in genetic research will be essential in the effort to identify novel
genetic causes of GI disease, reveal their molecular mechanisms, and translate them into therapy. The
outstanding laboratory, translational, and clinical research at CHOP and the Perelman School of Medicine
(PSOM) present an ideal environment for research career development in the genetics of pediatric GI disease.
The overarching goals of this training program are to:
• Train a cadre of committed researchers to investigate the genetic basis of pediatric GI disease and to use
this knowledge to improve the health of children and adults.
• Provide these individuals with the skill sets and foundation for career advancement.
• Encourage innovation and leadership in academic pediatric GI.
The Specific Aims of this training program are to:
• Identify, recruit and foster the career development of post-­doctoral research trainees from the pool of
CHOP GI fellows, PSOM GI fellows, and other scientists committed to training and career development in
the genetics of pediatric gastrointestinal disease.
• Match trainee strengths and interests with mentoring teams.
• Provide intensive mentored research experience and training with dedicated faculty.
• Provide career mentoring, including training on successful grant and manuscript preparation.
• Bring together faculty and fellows through seminar series and other academic activities to create a
collaborative community of physician-­scientists.
• Provide guidance for structured learning opportunities on the principles of genetic research, including
research ethics and the protection of animal and human subjects.
To achieve these goals, we have designed a program offering mentored independent research with a team
approach and scholarship oversight. The program provides career mentorship, including individualized
independent development plans (IDP) and workshops focusing on professional development and career
advancement skills. Seminars are focused on cutting edge research and progress in the field. In the first cycle
of funding, we have trained 6 outstanding fellows, 4 of whom have graduated and are pursuing successful
academic careers, 3 with additional funding. Our goal over the next 5 years is to build upon this foundation to
continuously improve our training program with innovative opportunities, and continue our mission of training
the next generation of physician scientists to investigate the complex genetics of GI disorders.

Public health relevance
PROJECT NARRATIVE Children are affected by a wide variety of diseases that impact the gastrointestinal system. The goal of this program is to train post-MD and -PhD researchers at the Children's Hospital of Philadelphia and the Perelman School of Medicine to successfully pursue careers dedicated to investigating the genetic basis of pediatric gastrointestinal, liver, and nutritional disease, and to use that knowledge to improve the health of children and adults.